Optimizing Sensory Feedback via Machine Learning and In-Silico Models

Amputation results in significant disability, pain, and global societal costs, particularly due to the loss of employ-
ment among young workers affected by such injuries. In Egypt, this issue is a major public health concern, largely
driven by high rates of labor-related injuries (mostly young workers), road accidents, and diabetes. While tradi-
tional prostheses can restore some motor control, they do not provide natural sensory feedback or alleviate
neuropathic pain, such as phantom limb and residual limb pain, that emerges after injury. Sensory stimulation
has been shown to restore sensory function, reduce phantom limb pain, and enhance prosthesis integration,
embodiment, and control. However, restoring sensory function in bionic prostheses remains a major challenge.
Thus, there is a critical need for advancing prosthetic technologies that restore sensory function, especially in
Egypt, where access to such innovations is limited. The objective of this project is to develop a proof-of-concept
machine learning-based approach for sensory feedback tuning. This project will integrate the computational neu-
roscience expertise of the US PI with the experimental and neural data analysis expertise of the Egyptian PI to
develop a stimulus coder that optimizes peripheral nerve electrical stimulation (eStim) parameters. The design
of this stimulus coder is innovative as it is comprised of an in-silico model that predicts the primary Somatosen-
sory cortex (S1) activity in response to a given tactile stimulus. The predicted S1 activity is then provided to an
eStim decoder that identifies the needed eStim parameters to evoke the predicted S1 activity. Our central hy-
pothesis is that using in-silico computational models to guide the development and operation of the stimulus
coder will result in effective naturalistic tactile sensations mimicking those elicited by normal touch. The devel-
opment of the proposed stimulus coder will be achieved through two specific aims. In Aim 1 of the project, a
tactile encoding in-silico model will be developed to simulate primary Somatosensory cortex (S1) activity in re-
sponse to tactile stimulation in rats (Task US-1). This model will be verified using recorded in vivo rat tactile data
(Task EG-1). Next, an eStim encoding in-silico model will be developed to simulate S1 activity in response to
sciatic nerve eStim (Task US-2). Similarly, this model will be verified using recorded in vivo rat eStim data (Task
EG-2). In Aim 2, using the eStim encoding model of Task US-2, expanded datasets will be generated using
combinations of different eStim parameters, each varied across a wide range, with their evoked neural responses
simulated (Task US-3). These datasets will be used to train different machine learning techniques for optimal
electrical decoding; that is, to identify the optimal eStim protocols to generate the desired S1 firing patterns (Task
EG-3). In addition, the eStim strategy most effective for training the decoder will be identified. Successful com-
pletion of this work will result in pilot data that demonstrates the feasibility of developing a smart, adaptable
sensory feedback mechanism that could support existing motor prostheses to add sensory capabilities. This is
expected to significantly improve the quality of life of amputees in Egypt, USA, and worldwide.

Public health relevance
Despite much effort to provide amputees with prosthetics that can restore motor functions, agility is hindered by the inability of the prosthesis to provide a naturalistic sensation of touched or grabbed objects. This proposal aims to explore the development of a proof of concept novel machine learning-based approach for automatically tuning peripheral nerve electrical stimulation, which we envision being utilized in prostheses to provide sensory feedback to amputees. This proposal is relevant to public health in both Egypt and USA because it will provide amputees with naturalistic sensory feedback percepts, thereby creating a significant impact on the quality of life for amputees.